Regulation of Cell Fate during Kidney Development and Disease

- Administrative Core
The Administrative component of the Pediatric Center of Excellence in Nephrology (PCEN) is charged with oversight and organization of all of the activities of Center. The Program Director, R. Ariel Gomez will be responsible for the scientific coordination, the direction of research emphasis and the overall administration of the Center. Drs. Patricio Ray and Maria Luisa Sequeira-Lopez, senior principal investigators (PIs) of two of the Center projects will assist him in scientific and administrative matters including the Pilot and Feasibility (P&F) program (Dr. Ray) and the Enrichment program (Dr. Sequeira-Lopez). The Executive committee, composed of Dr. Gomez and all the project PIs with the internal and external advisory committees will oversee the P&F program, the Enrichment program and the functioning of the Core. The internal and external advisory committee members are experts in the central scientific theme of the Center. Those advisors will visit and evaluate the whole program each year and make recommendations regarding the suitability, funding and continuation of P&F projects and the direction of the center. The Administrative component will continue to maintain a fully developed website that describes the Center, highlights the research accomplishments of individual projects and the Core in Single Cell Epigenomics, Transcriptomics and Bioinformatics, advertises the call for applications to P&F awards (in coordination with the 2 other PCENs), and publicizes the seminars and symposia provided through the Enrichment program. Furthermore, all the opportunities and activities will be advertised in the PCEN Twitter and Facebook accounts. The University of Virginia provides extensive research facilities with numerous additional core labs to guarantee an exceptional environment for the research activities of the Center investigators. In further support of the Center, the institution has committed funds for salary, reagents and educational enrichment activities. The PCEN will continue to collaborate with the adult Nephrology Division via a Pediatric and Adult Nephrology U2C/TL1 training grant, with the Integrated Translational Health Research Institute of Virginia (iTHRIV), the Center for Public Health Genomics, the new School of Data Science, the Cardiovascular Research Center (T32) and all the O’Brien and PCENs through the NOCKS series as well as establishing common PCEN workshops and annual symposia.

Public health relevance
NARRATIVE The burden of chronic kidney disease places enormous physical, psychological, social and economic stress on the affected children, their families and our society. This Pediatric Center of Excellence in Nephrology was designed to foster advances in knowledge, new methodologies, training and collaborations in an inclusive and diverse multidisciplinary environment to improve the management of infants and children with renal and urological diseases.